National Cancer Institute Early Career Cancer Clinical Investigator Award

Project Summary/Abstract
Dr. George has ongoing clinical trials that are evaluating novel combinations for the management of breast
cancer. This supplement will support the collaborative efforts between clinical investigators and basic scientists
to investigate biomarker driven strategies for further investigations. Based on these results, larger multi-
institutional studies will be opened within ETCTN and cooperative groups to propel therapeutic advancements
in breast cancer. Our goals and objectives align with the goals of the NCI to advance broad spectrum of cancer
research to develop effective tolerable therapies for our patients.

Public health relevance
Project Summary/Abstract Not required for submission to Administrative Supplement to Cancer Center Support Grants (P30 CCSGs).